Unraveling the contribution of gut microbiome in trichloroethene-mediated autoimmunity

ABSTRACT
Trichloroethene (trichloroethylene, TCE), an environmental and occupational agent, is known to cause
autoimmune diseases (ADs), including SLE-like disease in humans. The etiology of SLE is likely multifactorial,
which includes genetic, hormonal and environmental triggers. There is increasing evidence that environmental
factors, including changes in microbiota contribute to ADs. Using female MRL+/+ mice, we have established
that TCE causes early induction of the disease. Our preliminary studies in these mice also show that TCE
exposure leads to gut microbiome dysbiosis along with decreases in several important bacterial short-chain
fatty acids (SCFAs). However, the contribution and mechanisms by which gut microbiota lead to TCE-mediated
early induction of SLE are not known, and are the major focus of this proposal. We will test the central
hypothesis that TCE exposure in genetically susceptible populations causes gut microbiome dysbiosis and
impaired intestinal integrity together with mucosal immune dysregulation, which contribute to systemic
autoimmune responses and eventually lead to SLE. To achieve our overarching goal of understanding the role
of gut microbiome in TCE-mediated SLE, the following specific aims will be pursued. Aim 1 will establish that
TCE exposure causes its SLE-producing effects via dysbiosis of gut microbiota, and gut microbiota from TCE-
treated MRL+/+ mice can transmit SLE phenotypes to control mice. Using fecal samples, 16S rRNA and
metagenomic sequencing (WGS) will be performed to assess differential composition of the gut microbiome,
and differences in the functional genes. Furthermore, using feces from TCE-treated mice, fecal microbiome
transplant (FMT) studies will be performed in germ-free mice, which will firmly establish that altered
microbiome plays a causative role in TCE-mediated autoimmunity. Aim 2 will determine if TCE-microbiome-
host interactions contribute to disease outcome by affecting intestinal integrity and mucosal immunity. We will
measure gut permeability in vivo, tight junction proteins and endotoxin levels in the circulation. Contribution of
oxidative stress to epithelial permeability will also be assessed. We will also determine if TCE treatment skews
the Treg-Th17 balance towards a Th17 phenotype, along with intestinal inflammasome activation and
inflammatory cytokines. Adoptive transfer of Tregs will then be done to restore gut homeostasis. Aim 3 will
determine if imbalances in bacterial SCFAs contribute to SLE pathogenesis by affecting mucosal immunity and
barrier functions, and probiotic therapy can ameliorate TCE-mediated autoimmunity by restoring SCFAs. We
will examine profiles of SCFAs and mucosal Tregs during initiation and progression of the disease, and
conduct supplementation studies with SCFAs and probiotics to further establish the mechanisms by which
microbiota contributes to TCE-mediated SLE. Successful completion of these aims will establish the causal
role of gut microbiome dysbiosis in TCE-mediated SLE, delineate novel mechanisms contributing to disease
pathogenesis, and help in designing novel therapeutic microbial targets for autoimmunity/SLE.

Public health relevance
Project Narrative: Trichloroethene (TCE) is an extensively used organic solvent, especially for degreasing metals. A sizable human population is continuously exposed to this chemical both environmentally and occupationally, and TCE has been implicated in causing autoimmune diseases, including lupus (SLE)-like diseases in humans. The goal of this proposal is to establish the causal role of gut microbiome dysbiosis in TCE-mediated autoimmunity/SLE, provide novel mechanisms contributing to disease pathogenesis, and aid in designing novel therapeutic microbial targets for autoimmunity/SLE.